The role of transcriptional corepressor CtBP2 as a metabolic sensor in acute kidney injury

Project Summary
Acute kidney injury (AKI) is a common and severe complication in hospitalized patients, which is associated
with high morbidity and mortality rates. Patients who survive an episode of AKI are at increased risk for
progression to chronic kidney disease and end-stage renal disease. Therefore, there is a dire need to identify
therapeutic strategies to prevent or treat AKI. The kidneys have a high metabolic rate and substantial
decreases in the levels of nicotinamide adenine dinucleotide (NAD+) and NAD+/NADH imbalance impairs
energy generation and kidney function during AKI. Augmentation of NAD+ may protect kidney tubule against
diverse stressors. However, how NAD+/NADH imbalance contributes to development of AKI remains unknown.
Our preliminary studies involving a druggable genome screen have discovered an unexpected role of a
transcriptional repressor CtBP2 (C-Terminal Binding Protein 2) in renal epithelial cell death. CtBP2 is a
NAD+/NADH-dependent transcriptional repressor. Our studies show that CtBP2 is activated in ischemic,
nephrotoxic, and rhabdomyolysis-associated AKI. Moreover, in multiple mouse models of AKI, pharmacological
inhibition of CtBP2 mitigated renal impairment, suggesting a pathogenic role. Furthermore, we found that
CtBP2 is acetylated and this is critical for nuclear localization during AKI. Our ChIP-seq (chromatin
immunoprecipitation followed by sequencing) studies showed that CtBP2 transcriptionally suppresses many
genes involved in energy metabolism, including NAD+ biosynthesis in AKI. We hypothesize that CtBP2 is a
pathogenic regulator of RTEC dysfunction and cell death that regulates NAD+/NADH imbalance-mediated
metabolic dysregulation as a stress-induced metabolic sensor during AKI. To test this hypothesis, we will
investigate a role of p300 in nuclear localization and activation of CtBP2 in AKI (Aim 1) and determine a
pathogenic role of CtBP2 in renal injury and metabolic changes during AKI (Aim 2). These studies will
significantly advance our understanding of the molecular mechanisms of CtBP2 activation during AKI. These
outcomes will define novel molecular networks that underlie the severity of AKI and could lead to development
of CtBP2 inhibition as a novel therapeutic strategy.

Public health relevance
PROJECT NARRATIVE Acute kidney injury is a common illness among hospitalized patients with high morbidity and mortality and a common cause of irreversible chronic kidney disease. Therapeutic strategies for treating acute kidney injury are currently unavailable. This application proposes studies to determine how NAD+/NADH imbalance contributes to renal injury and might be applied in the future to treat or prevent acute kidney injury.